Pharmacokinetics and in vivo efficacy of DA1 macrocyclic peptides in a murine model of Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
JanusQ, LLC is a startup biotech company, spun out of Case Western Reserve University, that is developing
a peptide-based therapy for treatment of mitochondrial dysfunction in Alzheimer’s Disease (AD), which
erodes memory and cognitive ability in ~6 million Americans. The role of amyloid-β (Aβ) in AD pathogenesis is
poorly understood, and therapies addressing A have had limited success in the clinic. Like many other
neurodegenerative diseases, AD is linked to mitochondrial dysfunction that leads to neurotoxicity. The
mitochondrial protein ATAD3A, which spans both inner and outer membranes, is critical in cholesterol trafficking
and maintaining the mitochondrial nucleoid complex. However, during the stress of AD, ATAD3A oligomerizes
and inappropriately binds Drp1 (the mitochondrial-fission GTPase), causing mitochondrial fragmentation and
nucleoid instability. We have found that DA1, a linear peptide discovered by a JanusQ cofounder, prevents
ATAD3A oligomerization and association with Drp1, reduces mitochondrial fragmentation, improves nucleoid
stability, and—when delivered subcutaneously (SQ)—reduces behavioral and neurological deficits in mouse
models of AD. This success inspired the search for optimized macrocyclic peptides. In-vitro studies show that
one of these peptides—DA45—has 3-fold increased stability in mouse plasma, 30% improved potency, and
enhanced efficacy. This SBIR project has two aims, both designed to evaluate DA45 in vivo using the AD mouse
model 5XFAD: (1) Assess the pharmacokinetics (PK) of DA45 to test exposure and stability. Based on our
success with DA1, we will develop bioanalytical methods to extract DA45 from plasma and brain tissue for
quantitation by tandem liquid chromatography mass spectroscopy. Following peptide administration, we will
determine the time course of plasma and brain DA45 levels and calculate standard PK parameters. (2) Assess
DA45 efficacy. We will determine DA45 efficacy at doses of 0.032, 0.1, or 1 mg/kg/day SQ (aged 3–9
months), and assess ATAD3A oligomerization, mitochondrial bioenergetics, measures of AD pathology (e.g., Aβ
accumulation, synaptic integrity), and cognitive function during AD development. Besides generating the
necessary bioanalytical methods, the proposed work will determine whether DA45 has the pharmacological
properties—PK characteristics and dose-response for DA45 protection—necessary for advancement to
preclinical safety testing. An effective treatment would improve quality of life and survival of AD patients, reduce
reliance on medical caregivers and thus reduce overall medical costs. In the US, direct AD medical costs alone
exceeded $305B in 2020. This SBIR grant is a crucial step for JanusQ to develop an optimized DA1 peptide as
a breakthrough treatment for AD and would markedly enhance the ability of JanusQ to attract a
commercialization partner.

Public health relevance
PROJECT NARRATIVE JanusQ, LLC is a startup biotech company, developing novel drugs to treat Alzheimer’s disease (AD) by preventing key proteins in mitochondria from inappropriately binding to one another and damaging nerve cells in the brain. In mice, the original form of the drug markedly alters the course of the disease, improving long-term memory and cognition, leading to the development of an optimized version with substantially better behavior in vitro. This grant will allow JanusQ, in a mouse model of AD, to examine the behavior of the optimized drug in blood and brain, and test drug efficacy in treating AD.